KIDNEY DISEASE AND HYPERTENSION IN BLACKS

The pilot study for the kidney disease and hypertension in blacks grant is nearly completed. Eleven centers across the country randomized patients in this pilot study and will be moving on to the main trail.